Biomedical Research Vivarium

Project Summary/Abstract – Biomedical Research Vivarium
The Biomolecular Research Vivarium (BRV) provides a centralized location for standard care and housing of
research animals, development of model systems for human diseases, standard training for new users, and
advanced training for specialized procedures. The BRV was established with strong institutional support and
relies on experienced vivarium staff. The BRV is a critical resource for the COBRE in Matrix Biology and other
Boise State University investigators. The BRV will build on the current diverse user base to create a stable and
reliable revenue stream for sustainability during phase 3 and beyond. Continuing education for BRV staff will
ensure the highest level of support for investigators and access to innovative techniques as they become
available. Continued investment in the capabilities of the BRV through COBRE phase 3 funds in combination
with institutional support will allow the BRV to continue to provide innovative approaches for animal research
and assist in the BRV’s transition to sustainability. Due to its importance to research infrastructure, the
university is committed to providing dedicated space, upkeep of essential equipment, and training effort for
new investigators. Institutional support is provided for the Core Director, Attending Veterinarian, Animal
Research Manager, and Animal Care Coordinators. To foster a sustainable research environment, the BRV is
dedicated to supporting investigators by providing essential training, care, housing, regulatory oversight,
production, preservation and sharing of mice, rats, and zebrafish models in a timely and reliable manner.
Strengthening the BRV will meet the needs of investigators and further, will allow expansion of Boise State’s
biomedical research capabilities. The BRV will continue to enhance our biomedical research training and
education programs for graduate students by providing training in the responsible conduct of research. The
BRV will also provide essential research infrastructure necessary for collaborative research with nearby
colleges and universities who do not have access to such facilities. A business plan to allow sustainability will
be based on a fee-for-service model. Aims include 1) expanding the user base to ensure long-term
sustainability, and 2) maintaining effective management and operations for the core. The BRV will continue to
provide support to the research community well beyond phase 3 of the COBRE program.